Deferoxamine for the Prevention of Acute Kidney Injury

PROJECT SUMMARY
Acute kidney injury (AKI) is a common and often devastating complication of cardiac surgery, critical
illness, and other clinical settings. No pharmacologic therapy reliably prevents or treats AKI. Abundant data
from both animal models and humans indicates that iron plays a key role in the pathogenesis of AKI,
particularly in the setting of cardiac surgery. We propose a phase II, double-blind, randomized controlled trial
to test whether administration of the iron chelating agent, deferoxamine (DFO), prevents AKI following cardiac
surgery. We will enroll 300 adult patients at high risk of AKI following cardiac surgery at three major academic
medical centers in Boston. Patients will be randomly assigned, in a 1:1 fashion (n=150/group), to receive DFO
(30 mg/kg) or an equal volume of normal saline. DFO (or normal saline) will be administered as a continuous
24-hour intravenous infusion beginning immediately prior to surgery.
In Aim 1 we will test the effects of DFO compared to placebo on the incidence of postoperative AKI
(primary endpoint). AKI will be defined by changes in serum creatinine and urine output, according to the
KDIGO criteria. As secondary endpoints, we will assess longitudinal changes in urinary tubular injury markers,
NGAL and KIM-1. We will also test the effects of DFO on the incidence of the following common and
biologically plausible extrarenal postoperative endpoints: myocardial infarction, atrial fibrillation, delirium,
prolonged mechanical ventilation, and sepsis.
In Aim 2 we will tests the effects of DFO compared to placebo on longitudinal measures of circulating
iron and oxidative stress, and the inflammatory phenotype of monocytes. Serum iron parameters will include
catalytic iron – a toxic, non-physiologic iron species – as well as transferrin saturation and ferritin. Plasma
markers of oxidative stress will include F(2)-isoprostane and myeloperoxidase. We will also assess the effect
of DFO versus placebo on monocyte (CD14+) expression of IL-6, TNFα, and other markers of inflammation
using flow cytometry. In exploratory analyses, we will use next-generation RNA sequencing (RNA-Seq) to
assess the effect of DFO on the transcriptome of monocytes, which will facilitate discovery of novel transcripts
influenced by DFO. We will also determine the extent to which the effect of DFO on renal and extrarenal acute
organ injury (assessed in Aim 1) varies depending on the preoperative expression of key parameters
measured in Aim 2.
In aggregate, the studies proposed here will test a novel and promising therapeutic strategy for AKI
prevention. These studies have strong potential to improve clinical outcomes in patients at risk for AKI.
Further, the translational studies proposed here will yield important scientific insights into the role of iron
metabolism in the pathophysiology of AKI.

Public health relevance
PROJECT NARRATIVE Acute kidney injury (AKI) is a common and often devastating complication following cardiac surgery, in critical illness, and in other clinical settings, and no pharmacologic therapy reliably prevents or treats AKI. Abundant data suggest that iron excess plays a key role in AKI, particularly in the setting of cardiac surgery. We propose a 3-center, double-blind, randomized controlled trial (n=300) to test whether administration of the iron chelator, deferoxamine, prevents AKI following cardiac surgery in adult patients at high risk of AKI.